A Sleep Intervention to Improve Rehabilitation in Veterans with Chronic mTBI

Each year ~2.5 million people sustain a traumatic brain injury (TBI). Also a prominent general public health
issue, TBI is particularly prevalent in Veterans, with 60-80% reporting a history of TBI. Over 80% of all TBI are
categorized as mild TBI (mTBI), which is associated with a myriad of short- and long-term complications. Two
of the principal complicating factors associated with mTBI are sleep-wake disturbances (e.g., insomnia,
excessive daytime sleepiness, and circadian rhythm sleep disorders) and chronic pain, including headache
and diffuse/global pain. Sleep-wake disturbances and chronic pain have an independent prevalence of ~70%,
individually impair quality of life, impede effective rehabilitation, and have staggering economic impacts.
Furthermore, there is a strong bidirectional relationship between sleep-wake disturbances and pain such that
impaired sleep exacerbates pain, which leads to greater impairments in sleep and worse pain. This vicious
cycle between sleep disturbances and pain, which is a particularly prevalent and detrimental condition in
Veterans with chronic mTBI, represents a central challenge precluding effective treatment and ultimately,
improving Veteran quality of life. Although there are pharmacological and non-pharmacological therapies for
chronic pain, the presence of TBI significantly complicates the effectiveness of these treatment options, and
have significant adverse effects (e.g., long-term prescription opioid dependence, misuse, and overdose). We
believe there is profound potential to intervene at the sleep level, and, by improving sleep quality, enable
Veterans with chronic mTBI to better manage their pain and end this vicious cycle.
This proposal aims to apply a sleep intervention to improve chronic pain in Veterans with mTBI. We propose to
use morning bright light therapy (MBLT), a readily deployable, cost-effective, non-pharmacologic, and home-
based sleep intervention, to improve sleep-wake disturbances and therefore ameliorate chronic pain and
improve quality of life in Veterans with chronic mTBI. There is substantial scientific precedent for MBLT to be
effective in improving sleep quality, as outlined by a recent meta-analysis of 53 MBLT-based studies. Indeed,
the potential of MBLT to improve sleep quality in Veterans with chronic mTBI remains unexplored, and yet,
highly promising, especially in light of our exciting preliminary data supporting study feasibility and potential
effectiveness. Our central hypothesis is that MBLT will improve sleep quality and ameliorate pain, resulting in
improved quality of life in Veterans with chronic mTBI.
Specific aims designed to test our hypothesis are to determine the effect of MBLT on, 1) sleep, 2) pain, and 3)
quality of life, in Veterans with chronic mTBI. We propose to recruit n = 100 Veterans with mTBI from the VA
Portland Health Care System, randomized 1:1 to MBLT (10,000 lux light exposure for 30 min within 90 min of
waking for 4-weeks) or a no-light sham-MBLT condition (as previously published using the same
duration/timing). Sleep quality will be assessed through self-report questionnaires and 24/7 actigraphy
monitoring. Pain will be evaluated through self-report questionnaires and two quantitative methods
(conditioned pain modulation and pressure algometry). Quality of life will be measured through self-report
questionnaires. Outcomes will be assessed pre- and post-intervention, and at a 3-month follow-up time point.
It is expected the proposed work will demonstrate MBLT is a viable method for improving sleep quality,
ameliorating chronic pain and improving quality of life, in Veterans with mTBI. Improvements in pain and quality
of life will positively correlate with objective markers of improved sleep quality. These data would demonstrate,
1) an effective treatment option, alone or in combination with existing rehabilitative efforts, in Veterans with
mTBI, and 2) sleep-wake disturbances may be implicated in the pathogenesis of these functional impairments,
thereby establishing greater precedent for targeting sleep as a meaningful primary and/or adjunctive
rehabilitative therapy.

Public health relevance
Traumatic brain injury (TBI) is a major cause of disability in the Veteran population, often resulting in chronic pain and sleep disturbances, among other sequela. Extensive rehabilitative efforts are usually required and often prevent return to the workforce and community. Disturbed sleep and excessive daytime sleepiness are among the most pervasive and enduring sequelae after TBI, which we hypothesize is a significant contributor to these functional impairments and an impediment toward rehabilitation. Thus, our research aims to enhance sleep quality as a means to reduce pain and improve quality of life and functional outcome measures in Veterans with TBI. We predict that the proposed intervention, morning bright light therapy, if found effective, will be cost-effective, rapidly deployable, and highly accepted by Veterans with TBI.